ARGININE FREE DIET AND DIETARY SUPPLEMENTATION WITH GLUTAMATE AND CITRULLINE

Animal and in vivo studies suggest that citrulline can substitute for arginine in maintaining arginine homeostasis and NO formation. The hypothosis will be tested by conducting a long-term dietary study (1 week control, 4 weeks experimental diet) with a control, arginine-free, arginine-free citrulline supplemented and arginine-free glutamate supplemented diet.